Mechanisms and interventions addressing accelerated cardiovascular disease risk in women with endometriosis

ABSTRACT (Parent Grant)
Endometriosis is a debilitating estrogen-dependent gynecological disorder deriving from the presence of
endometrium like tissue in sites outside the uterine cavity. Approximately 6-10% of women have
endometriosis and suffer from symptoms including chronic pelvic pain, pain during intercourse,
infertility, and other co- morbidities associated with systemic inflammation. The widespread nature of
this disease extends to impact overall health, including contributing to elevated risk of cardiovascular
disease (CVD) --the leading cause of death in women. Endometriosis and atherosclerotic CVD are
both inflammation-induced diseases. Estrogen exposure is beneficial for women from a CVD standpoint,
but the standard of treatment for endometriosis includes estrogen suppression. This creates a
conundrum for the long-term management of CVD risk in womenwith endometriosis. This proposal fills a
significant gap in prior research into the role of inflammatory signaling, CVD risk and effective
interventions to mitigate cardiovascular comorbidities. Circulating oxidized lipids and inflammatory
cytokines that are elevated in women with endometriosis stimulate the ubiquitously expressed
scavenger lectin-like oxidized LDL receptor (LOX-1) on the vasculature resulting in pronounced
endothelial dysfunction, one of the earliest detectable indicators of increased CVD risk. Estrogen directly
inhibits LOX-1- dependent endothelial dysfunction and thus the standards of care for endometriosis
treatment may be exacerbating CVD risk. Our working model is that endometriosis-associated systemic
inflammatory mediators increase LOX-1 receptor activity and result in endothelial dysfunction. Our global
hypothesis is that in women with endometriosis increased CVD risk is the result chronic systemic
inflammation inducing endothelial dysfunction, mediated through LOX-1 receptor, and this CVD risk is
exacerbated by standard estrogen suppression treatments. In this application, we use a multipronged
approach including in vivo and ex vivo human physiological experiments to determine the role of
inflammation and estrogen suppression on cardiovascular specific outcomes in the setting of
endometriosis. This series of studies in women with endometriosis will delineate the roles of estradiol
(Specific Aim 1) and systemic inflammation (Specific Aim 2) in endometriosis- associated accelerated
CVD risk. These studies will evaluate novel signaling mechanisms including the linkage common to
both CVD and endometriosis through the downstream activation of the ubiquitous scavenger receptor
LOX-1. We will also test the effects of two distinct interventions (Specific Aim 3) including the selective
estrogenreceptor modulator bazedoxifene, and the statin simvastatin in mitigating CVD risk in women with
endometriosis. Our studies have the potential to identify clinically relevant therapeutic targets and
interventions thus decreasing CVD burden in women with endometriosis.

Public health relevance
NARRARIVE (PARENT GRANT) Endometriosis is a debilitating estrogen-dependent gynecological disorder associated with chronic pelvic pain and a myriad of comorbidities associated with systemic inflammation including elevated cardiovascular disease (CVD) risk. We take an integrative physiology approach to examine the role of estrogens and LOX-1 receptor mechanisms mediating the increased CVD risk through parallel inflammatory mechanisms, and to examine two emerging interventions that have shown efficacy for reducing symptoms and long-term CVD risk in women with endometriosis. These studies have the potential to identify clinically relevant therapeutic targets and interventions to decrease CVD burden in women with endometriosis.